Pre-mRNA Processing and Function of Alternatively Spliced Isoforms of TFPI

Hemostasis is a constant balancing act between pro- and anticoagulant factors, platelets, and the vasculature
that is required to prevent excessive bleeding or pathological clotting. The anticoagulant, Tissue Factor
Pathway Inhibitor (TFPI), is a vital factor in this balance and modulates a broad range of bleeding and clotting
disorders through inhibition of TF-FVlla, FXa, and prothrombinase (FXa-FVa). The TFPI gene is evolutionarily
conserved and due to alternative splicing, different TFPI isoforms are predominant within distinct pools. While
the specific inhibitory function of each TFPI isoform has been characterized, little is known regarding
differences in isoform-specific contributions under prothrombotic disease conditions such as Factor V Leiden
(FVL) and during embryonic development. Further, the pre-mRNA splicing and processing mechanisms
dictating expression of each isoform are unknown. As a causal relationship exists between aberrant splicing of
FV and TFPI isoform-specific function in human bleeding disorders, these mechanisms, coordinated by precise
cues directed at maintaining the hemostatic balance, are highly relevant. Thus, the long-term objective of this
proposal is to differentiate the physiological, site-specific production of each TFPI isoform at a molecular level
and define their anticoagulant function in embryonic development and disease. TFPla is the only isoform
present in platelets and the only isoform that inhibits prothrombinase during the initiation of blood coagulation.
Additionally, global TFPI deficiency results in prothrombotic perinatal lethality in FVL mice, and TFPla
prothrombinase inhibitory activity is reduced in the presence of FVL. To this end, K99 phase studies revealed
that TFPla and its inhibition of FVL-containing prothrombinase play an important role in placental angiogenesis
and embryonic survival and further characterized the biological activity of new platelet-specific TFPla splice
variants identified in mice and humans. The R00 phase studies will leverage the evolutionary conservation of
alternative TFPI splice forms and splicing signals embedded in highly conserved sequences to determine cisRNA element and trans-acting splicing factor interactions regulating TFPI isoform diversity in mice and
humans. Deciphering the pre-mRNA processing mechanisms that regulate site-specific TFPI isoform
expression will delineate how alternative splicing contributes to the physiological and pathophysiological
hemostatic balance during embryonic development and in adulthood. As there are many patients with bleeding
and clotting disorders of unknown cause, the relation of aberrant splicing to these diseases represents a
relatively new and unexplored area with great potential for launching a successful independent career. This
work will establish an innovative research program at the intersection of RNA biology and coagulation,
enabling the Pl to lead a uniquely interdisciplinary investigation into how splicing regulation influences platelet
function and thrombotic risk. The R00 phase will provide the foundation for future R01-level studies and
sustained contributions to the fields of thrombosis and hemostasis and RNA regulation.

Public health relevance
Project Narrative More than 3 million Americans have a bleeding disorder that could be deadly without treatment, while conversely, around 900,000 Americans each year are affected by a blood clot, resulting in nearly 100,000 - 300,000 deaths. As many patients still suffer from bleeding and clotting disorders of unknown cause, this proposal will probe previously unexplored molecular mechanisms involved in the production and function of different forms of blood proteins that are constantly working together to prevent unnecessary bleeding and clotting throughout all stages of life. Furthering our understanding of these mechanisms and their dysregulation, has important implications for improving the treatment of bleeding and clotting disorders.